Regulation of the Timing and Spatial Patterning of Zygotic Genome Activation During Embryogenesis

Abstract
Transcription is initially repressed during early embryo development and then globally activates in a processed
called zygotic genome activation (ZGA). The precise timing of ZGA is critical for embryo development: delaying
ZGA blocks gastrulation and cell differentiation; premature ZGA induction disrupts normal development.
However, the nature of ZGA regulation and the identity of factors that control its onset have remained elusive.
Three models have been proposed to explain the onset of ZGA: 1) embryos contain a timer or clock, 2) a sizer
that measures cell volume, or 3) an event counter that tracks cell divisions. A timer could consist of maternal
mRNAs encoding proteins, such as pluripotency factors, that are steadily translated after fertilization and
whose accumulation induces ZGA. The sizer hypothesis supposes that when cells achieve a sufficiently small
volume they reach a threshold DNA:cytoplasm ratio that overcomes a global block of zygotic transcription.
Histones and DNA replication factors have been implicated in setting this block. The molecules that constitute
a cell cycle counter are unknown. Time, cell size, and cell cycle number are intertwined, therefore it has been
challenging to determine whether one or all of these parameters controls ZGA. Ultimately, our understanding
of embryonic genome activation has been hampered by an inability to measure cell-to-cell variability in an
embryo, a lack of genetic tools to deplete maternal factors implicated in ZGA regulation, and the challenge of
altering cell or embryo dimensions. My lab recently developed a state-of-the-art technique to image ZGA in
time and space at single-cell resolution in whole cleavage-stage embryos by labeling newly synthesized RNA
with 5-ethynyl uridine (5-EU). Using this technique, we distinguish between ZGA regulatory mechanisms
based exclusively on a timer, sizer or counter. In Aim 1, we will construct a spatial map of genome activation in
single-cells of Xenopus and zebrafish blastula embryos. Additionally, by constricting embryo dimensions, we
will generate mini-embryos to distinguish genome activation that is initiated by a cell cycle counter from or a
cell volume sensor. In Aim 2, we will characterize the mechanisms by which core histones regulate ZGA onset,
using a stem loop binding protein 2 mutant zebrafish embryos that contain significantly reduced levels of core
histones. In Aim 3, we will determine whether translation of pluripotency factors constitutes a timer for
triggering ZGA. The premise of this application is that a single model cannot explain the precise timing and
patterning of ZGA. Specifically, we hypothesize that cells must reach a threshold size to relieve histone-based
repression, and contain a sufficient level of pluripotency factors to induce zygotic transcription. The research
proposed here will provide a new mechanistic understanding of embryonic genome activation – a universal
feature of developmental in all vertebrates, including humans - and how specific combinations of regulatory
paradigms dictate patterning and timing of zygotic transcription.

Public health relevance
Project Narrative Zygotic genome activation (ZGA) is a universal feature of embryogenesis in all vertebrate organisms, including humans. The precise timing of ZGA is critical for subsequent development: delaying or prematurely inducing ZGA disrupts normal development. The proposed studies will provide a new dimension to the field, revealing the spatial and temporal regulation of ZGA, at single-cell resolution for whole embryos.